Characterization of European American and African American Sarcoidosis via Immunogenetics

ABSTRACT
Sarcoidosis is a granulomatous inflammatory disease often dubbed a “medical mystery” yet significantly
understudied. While it is known that sarcoidosis likely involves host genetic susceptibility and an innate and
adaptive immune response to infectious, organic or inorganic agents, the mechanisms by which granulomas
form and the determinants of severity and manifestation of disease remain elusive. Over the past several
years, our team has led the charge to define the role of genetics in sarcoidosis. Specifically, under our current
funding, we have published 13 papers with 3 more soon to be submitted describing genes for susceptibility,
severity, ancestry specific and organ-specific effects. However, the mechanism(s) by which associated genetic
variants influence sarcoidosis are still largely unknown. Our proposal will close this knowledge gap by
characterizing functional variants and the tissue(s) in which they operate by 1) identifying differentially
expressed (DE) genes in granulomatous tissue and blood, 2) characterizing the expression of DE and
previously associated genes by specific cell type, 3) identifying tissue or cell-specific eQTLs for DE and
previously associated genes, 4) creating clinical profiles of patients carrying risk alleles and 5) replicating our
findings in an independent cohort. Specifically, in Aim 1, we will identify novel candidate genes and their
most likely causal variants to be investigated in our future mechanistic studies of sarcoidosis susceptibility
and persistence via DE analysis of RNA sequencing data of whole blood from both EA and AA sarcoidosis
patients and matched controls AND DE analysis of granulomatous tissue from a subset of these same patients
compared to healthy tissue. Additionally, we will perform eQTL analysis using the transcriptomic data from
blood and tissue described above and ancestry-informative genome-wide genotyping data. In Aim 2, we will
define the cell subsets in which the most likely causal variants operate and identify novel cell-specific
effects by DE analysis of RNA sequencing data from blood-derived single cells in our cohort of EA and AA
cases and matched controls. In order to identify cell-type specific eQTLs, analysis of the genotype and single
cell transcriptomic data will also be performed. Finally, in Aim 3 we will replicate our list of candidate
genes, their most likely causal variants and the specific cell type in which they influence disease using
blood, tissue and single cells from a cohort of patients recruited based on the demographic and clinical criteria
that are associated with our causal variants. Our work will be greatly facilitated by the extensive genotype,
clinical and environmental data on our existing cohort AND the recently established Sarcoidosis Research Unit
from both of which we have strong preliminary data to support the studies proposed herein. In summary, when
this grant is complete, we will know the likely causal variants, the tissue and cell-types in which they function
and the clinical characteristics of the patients in which they are most likely to be enriched from which detailed
mechanistic experiments can be designed.

Public health relevance
Sarcoidosis is a debilitating disease that affects both African and European Americans, women and men. It involves a dysregulation of the immune system and includes both environmental and genetic risk factors. Identifying likely causal variants and characterizing the tissues and cells in which they are active will bridge a significant gap in our understanding of sarcoidosis and allow us to mechanistically investigate its etiology and pathology.